VOLUME REGULATION IN NORMAL AND CATARACTOUS LENSES

DESCRIPTION (provided by applicant): The lens generates an internal circulation of solute, which is followed by fluid to create a micro circulatory system for this avascular organ. The circulation depends on fiber cell gap junctions to conduct intracellular fluxes of ions and perhaps fluid, which flow from the center to surface of the lens. Extracellular fluxes move from the surface to center of the lens along the spaces between fiber cells. The intracellular and extracellular fluxes are linked by fiber cell membranes, which express nonselective cation channels, chloride channels and the water channel AQP0. The transmembrane flux of solute creates small transmembrane osmotic gradients that generate the circulation of fluid. The circulation is critical for homeostasis in central fiber cells, which rely on the inwardly directed extracellular fluid flow to carry essential nutrients, amino acids and antioxidants into the lens. We have spent many years characterizing the molecular basis of the lens circulation and have made enormous progress (reviewed in Mathias et al., 2008), but there are still questions, as outlined in aims 1 and 2 of this proposal. In the last grant period, we began the process of putting together what we have learned to understand generation of the age-onset central cataract. Based on our findings, the overall hypothesis for this proposal is: The age-onset nuclear cataract is a consequence of compromise of the lens circulation due to cumulative oxidative damage to transport proteins. Aim 3 of this proposal will directly address this hypothesis. Moreover, we need to understand how a normally functioning circulation depends on lens transport parameters, and how these parameters can be altered by cumulative oxidative damage. Aim 1 is to further characterize gap junction coupling in the normal lens. It involves testing 2 hypotheses. 1a) Intracellular water flow in the lens is mediated by gap junctions. 1b) The equator to poles variation in gap junction coupling conductance is due to regulation of Cx50 channels through the MAP kinase pathway. Aim 2 is to further characterize lens water channels. It involves testing 2 hypotheses. 2a) AQP0 has a specialized role other than providing a water channel. 2b) AQP0 is physiologically regulated by pH and [Ca2+]i. Aim 3 is to characterize the effects of cumulative oxidative damage on lens transport and intracellular homeostasis. It involves testing 2 hypotheses. 3a) Oxidative stress in the lens causes reductions in gap junction coupling conductance, leading to compromise of the circulation and eventual cataracts. 3b) Oxidation-mediated reductions in lens gap junction coupling are initiated through activation of PKC3. To achieve these aims we will use standard biochemical techniques and several specialized techniques that were developed by us. The distribution of functional gap junction channels will be evaluated using whole lens impedance techniques. Osmotic studies of isolated fiber cell membrane vesicles will determine water permeability and its regulation by pH and calcium. Microelectrode based techniques will be used to measure the spatial distribution of intracellular hydrostatic pressure, and intracellular sodium and calcium in intact lenses. Most studies involve lenses from genetically altered mice that express modified transport proteins or other enzymes.

Public health relevance
PUBLIC HEALTH RELEVANCE: The work described in this proposal is designed to further our understanding of the lens circulation, and how cumulative oxidative damage to transport proteins can compromise the circulation and lead to age-onset central cataracts. Our hypothesis is oxidative damage to gap junction coupling in the lens is the first step that initiates a cascade of events leading to central cataracts. If so, there are pharmacological interventions that can up regulate gap junction coupling, such as inhibitors of PKC3, and these could potentially prevent development of the cataract. PROJECT NARRATIVE The work described in this proposal is designed to further our understanding of the lens circulation, and how cumulative oxidative damage to transport proteins can compromise the circulation and lead to age-onset central cataracts. Our hypothesis is oxidative damage to gap junction coupling in the lens is the first step that initiates a cascade of events leading to central cataracts. If so, there are pharmacological interventions that can up regulate gap junction coupling, such as inhibitors of PKCγ, and these could potentially prevent development of the cataract. __SpecificAimsTextDelimiter__ SPECIFIC AIMS In the avascular lens, transmembrane ion transport generates a circulation of solute that is followed by fluid (reviewed in Mathias et al., 2007), creating a micro circulatory system. The ionic currents associated with this circulation are very large by epithelial standards, they flow in a dramatic pattern into, around and through the lens (see Fig 1), and they are found in every lens studied. One therefore assumes the circulation is critical for homeostasis, particularly for central fiber cells (Mathias et al., 2007). Moreover, we have shown that compromise of this circulation leads to central cataracts (Gong et al., 1998; Wang et al., 2008). The working hypothesis for the studies proposed here is: The age-onset nuclear cataract is a consequence of compromise of the lens circulation due to cumulative oxidative damage to transport proteins. To test this novel hypothesis, we need to understand how a normally functioning circulation depends on lens transport parameters, and how these parameters can be altered by cumulative oxidative damage. A central component of the circulation is gap junction coupling, which will be studied in Aim 1. Lens water channels are also critical, and they will be studied in Aim 2. In Aim 3, we will investigate changes in transport parameters and intracellular homeostasis in mouse knockout (KO) models that have compromised protection against oxidative damage. Aim 1. To characterize gap junction coupling in the normal lens. 1a) To test the hypothesis: Intracellular water flow in the lens is mediated by gap junctions. We recently published a theoretical study showing gap junction-mediated cell to cell water flow would be driven entirely by hydrostatic pressure and not osmosis. Radial gradients in hydrostatic pressure in connexin knockout/knockin lenses will be measured with a new pressure sensing microelectrode-based system. Preliminary studies using this system suggest there is about a 300 mmHg intracellular pressure gradient between the lens core and periphery, and this gradient is reduced when gap junction coupling is increased. 1b) To test the hypothesis: The equator to poles variation in gap junction coupling conductance is due to regulation of Cx50 channels through the MAP kinase pathway. Work by others (Shakespeare et al., 2009; Boswell et al., 2008; 2009) suggested involvement of the MAP kinase pathway, whereas our preliminary data suggest Cx50 channels are required for the variation in coupling. Whole lens impedance studies of the variation in coupling conductance will be measured in Cx50 KO lenses, and in WT lenses with the MAPK pathway blocked, or with Cx50 channels blocked with the specific inhibitor mefloquine. Aim 2. To characterize the physiological properties of AQP0 water channels in lens fiber cells. 2a) To test the hypothesis: AQP0 has a specialized role other than providing a water channel. We have made a unique transgenic mouse that expresses AQP1 in fiber cells and crossed these mice with AQP0- /- mice to create a lens that has only AQP1 (Tg-AQP1,AQP0-/-). The Tg-AQP1 lenses are normal in all regards. At 2 months of age, the AQP0-/- lenses are undersized and have a dense cataract. The Tg- AQP1,AQP0-/- lenses have significant increases in size and transparency, nevertheless the rescue is not complete and the initially mild cataract intensifies with age. AQP0 is known to interact with fiber cell gap junction proteins Cx46 and Cx50, so lack of AQP0 could affect gap junction coupling and the lens circulation. To determine effects on the lens circulation, we will measure lens impedance, [Ca2+]i and [Na+]i in the Tg- AQP1,AQP0-/- lenses compared to known results from WT lenses. AQP0 is known to interact with lens crystallins and the cytoskeletal proteins filensin and CP49, and this interaction might stabilize lens structure. Pull down assays in Tg-AQP1,AQP0-/- lenses will be used to determine if AQP1 interacts with lens crystallins, filensin and CP49, as does AQP0. We will use EM to examine the Tg-AQP1,AQP0-/- to determine cellular structure and if AQP1 forms square array cell to cell junctions as does AQP0. 2b) To test the hypothesis: AQP0 is physiologically regulated by pHo and [Ca2+]i..It has been shown that AQP0 water permeability is regulated by pHo and [Ca2+]i, but the concentration-dependence has not been determined, so it is not known whether this regulation occurs in the range of concentrations found in the lens. Water permeability will be measured by the rate of osmotic swelling/shrinking of fiber cell membrane vesicles and determined as a function of both pHo and [Ca2+]i. Vesicle [Ca2+]i will be determined using Fura2. Aim 3. To characterize the effects of cumulative oxidative damage on lens transport and homeostasis. 3a) To test the hypothesis: Oxidative stress in the lens causes reductions in gap junction coupling conductance, leading to compromise of the circulation and eventual cataracts. KO of GPX-1, an enzyme that protects the lens against H2O2-mediated oxidative damage, caused early (2 months age) reductions in coupling and increases in [Ca2+]i and [Na+]i (Wang et al., 2009) as well as eventual (14 months age) reductions in fiber cell membrane water permeability (preliminary data). To determine whether these are general properties of oxidative damage or a specific effect of GPX-1 KO, SOD1 and SOD2 KO mice and a mutant catalase mouse will be obtained from Jackson labs and studied as were GPX-1 KO lenses. In addition, we will biochemically characterize the KO lenses using assays for calpain activity, ascorbic acid concentration, and protein glycosylation; we will use crystallin specific antibodies to immuno blot NaOH-soluble and insoluble fractions; we will use mass spectrometry to determine protein modifications due to oxidation; and we will use EM to examine cellular and gap junction structure. These will be done in 2 and 14 month old KO and WT lenses. 3b) To test the hypothesis: Oxidation-mediated reductions in lens gap junction coupling are initiated through activation of PKCγ. Lin & Takemoto (2005) showed PKCγ is activated through oxidation of Cys residues in its C1 domain. Activation of PKCγ has been shown to reduce fiber cell gap junction coupling (Zampighi et al., 2005; preliminary studies). In 2 mo old GPX-1 KO lenses, gap junction coupling is reduced but AQP0-mediated water permeability is normal, suggesting the earliest effects of oxidative damage are specific to gap junctions. These observations suggest hypothesis 3b. PKCγ oxidation and activity will be measured in GPX-1 KO lenses. PKCγ KO mice will be crossed with GPX-1 KO mice. The same studies as described in Aim 3a will be done in 2 mo and 14 mo old GPX-1-/-,PKCγ-/- lenses and compared to PCKγ-/- lenses.